Precision Aging Network: Closing the Gap Between Cognitive Healthspan andHuman Lifespan

SUMMARY/ABSTRACT: Overall Project
The strategic vision of the Precision Aging Network (PAN) is to develop the essential scientific knowledge to
understand the discrepancy that currently exists between cognitive healthspan and human lifespan. We must
reveal the neural mechanisms that 1) account for optimal brain performance in old age resulting in healthy
cognitive function, and 2) those that underlie decline in brain function leading to age-related cognitive
impairment (ARCI), Alzheimer’s disease (AD), or Alzheimer’s disease-related dementias (ADRD). The ultimate
goal of the PAN is to develop not only a strong scientific foundation for the essential knowledge needed to
match cognitive healthspan with human lifespan, but also to leverage big data approaches that apply precision
medicine concepts to prolong optimal brain function. To achieve this goal of sustaining optimal cognitive
function in old age, and to extend quality of life for people across levels of risk for ARCI, AD, or ADRD,
we maintain that methodologies such as those developed and implemented in the PAN will be required.
Although ‘chronological age’ is consistently associated with increasing incidence of disability, including chronic
brain disorders such as AD and ADRD, the exact mechanistic relationships between ‘biological age’ and
decline in brain function is not known. The number of people now living with some form of dementia is
estimated to be 50 million worldwide, which is expected to double every 20 years. Because of the enormous
heterogeneity in brain and cognitive function among individuals in their 70s, 80s and 90s, the urgent challenge
for science, medicine and healthcare providers is to discover interventions that are individually effective in
delaying or preventing ARCI, AD, or ADRD.
Untangling the complex relationship between age and cognitive performance requires a strategy that includes
the study of very large, diverse, well-characterized and longitudinally sampled populations. This will require
‘big data’ but also the means to translate the massive amounts of information gathered into ‘smart data’ or
‘knowledge’. This demands radically different conceptual models. Currently, no single approach adequately
identifies the means to modify personal aging trajectories for improved brain health in individuals. The
approach proposed in PAN is designed to overcome obstacles of earlier methods. The focus is on how to
distinguish the various combinations of age, sex, genetics, race-ethnicity, health, lifestyle choices and
environmental factors that influence brain drivers that increase susceptibility to dysfunction, as well as
those factors that increase brain protection and resistance against dysfunction.
The fundamental principle of the precision medicine approach is to ’individualize’. This will enable strong
and specific predictions for each person to close the gap between cognitive healthspan and human
lifespan. The root of this concept is in the teachings of Hippocrates, who said – “It is more important to know
what sort of person has a disease than to know what sort of disease a person has.”

Public health relevance
Overall Project Narrative The strategic goal of the Precision Aging Network is to develop the essential scientific knowledge and appropriate technologies to predict individual brain health risks and to discover personalized solutions to maximize cognitive healthspan. Because of the enormous heterogeneity in brain and cognitive functions among older individuals, the urgent challenge for science, medicine and healthcare providers is to discover interventions that are individually effective in delaying or preventing the onset of symptoms that arise from age- related cognitive impairment or brain disorders such as Alzheimer’s disease (AD) and AD-related dementias. To achieve this we will determine how specific categories of risk relate to brain aging and cognitive outcomes.